Integration of a collaborative care model for mental health services into HIV care for pregnant and postpartum women in Kenya (the Tunawiri Study)

Common mental disorders (CMD) of depression and anxiety are prevalent and largely untreated among Kenyan
pregnant and postpartum women living with HIV (PPWH). CMD lead to poor maternal and child health outcomes
and contribute to lack of HIV care engagement and virologic failure in PPWH. While efficacious treatments for
CMD exist, scaling treatment within routine health care in low- and middle-income (LMIC) settings will require
stakeholder engagement and both effectiveness and implementation data to inform scale up and sustainability.
Our team has integrated other efficacious interventions into antenatal (ANC) and HIV care in Kenya. We now
propose to integrate proven mental health services using a collaborative care model, combined with a low
intensity evidence-based intervention (problem solving therapy), while targeting known social determinants of
HIV-related health for PPWH (stigma and IPV). Building on the current multidisciplinary approach for HIV care
in Kenya, our proposed Collaborative Care Model (CCM) will utilize existing peer mentor mothers, non-specialist
behavioral care managers, and psychiatric nurses; and will incorporate a consultant psychiatrist into the
ANC/HIV care team. Guided by the EPIS (Exploration-Preparation-Implementation-Sustainment) framework, the
overall study goal is to integrate collaborative care for perinatal CMD within routine ANC/HIV services in
Kenya, assess the costs and cost-effectiveness of this approach, and work with policy and decision makers to
determine key considerations for scale-up. Specifically, in Aim 1, we will identify contextual barriers and
facilitators to refine an optimal integration model for delivering collaborative care model using multi-
method data collection (focus groups with providers, in-depth interviews with key informants, and a clinic
readiness checklist). A workshop with our Advisory Board comprising both county and national level stakeholders,
will allow us to translate findings into a locally relevant CCM. In Aim 2 we will test CCM
PPWH
health
during
depression
retention Aim 3, we will
refine CCM implementation strategies through cost-effectiveness and dissemination research. We will
carry out costing and cost-effectiveness analysis and invite policy and decision-makers to participate in a nominal
group technique process to elucidate factors for further scale up and sustainment of the CCM approach. Findings
from this study will developing a scalable model adaptable to other LMIC settings, contributing to global HIV and
maternal health goals while and addressing the burden of untreated CMD.
in antenatal care for
in a hybrid type 2 implementation-effectiveness trial using a stepped wedge design at 15 primary
care facilities in southwestern Kenya . We will i ntroduce CCM care for PPWH diagnosed with CMD
antenatal care. The co-primary health outcomes at 12 months postpartum will be (1) recovery from
or anxiety symptoms in PPWH, and (2) proportion PPWH with sustained viral suppression and
in HIV care. Key implementation outcomes are feasibility and acceptability. Finally, in

Public health relevance
Project Narrative Our proposal seeks to improve mental health, pregnancy, and HIV outcomes among pregnant and postpartum women living with HIV with common mental health disorders in Kenya. We will tailor a collaborative care model for peripartum women with HIV experiencing mental health symptoms and evaluate its impact on their mental health, antenatal, and HIV care outcomes. We will actively engage key stakeholders throughout the process and assess scalability and sustainability through multi-method approaches. This study will contribute to the overall goal of achieving optimal health outcomes for women living with HIV and their families in sub-Saharan Africa.